Using a discrete choice experiment to determine preferences for STI testing models for Black adolescent males

PROJECT SUMMARY
Of the 26 million new sexually transmitted infections (STI) in 2018, almost half were among adolescents (15-19
years old) and young adults (20-24 years old). Millions of cases remain undiagnosed and untreated, particularly
among male teens. Less than 3% of sexually active male teens have had an STI test in the past 12 months
versus 26% of their female peers. Male teens are more likely to forego testing than female teens due to greater
confidentiality concerns, cost/insurance barriers, and lower self-perceived risk. COVID-19 has exacerbated
barriers to STI care, as testing services have plummeted by 66% since March 2020. There is great urgency to
develop innovative and effective methods to screen adolescent males for STIs: as males are largely
asymptomatic, their untreated STIs can be transmitted unknowingly to other sexual partners. Untreated STIs can
lead to male and female infertility and increase one’s susceptibility to contracting HIV. The objective of this R21
is to use an innovative, user-centered approach, a discrete choice experiment, to determine the preferences for
STI testing models among Black adolescent males. In a discrete choice experiment (DCE), a methodology that
has been widely used to inform the design/adoption of health services, respondents are presented with two
services with different attributes and are asked to choose which one they prefer (e.g., Testing Model A or B).
This series of choice-tasks elucidates the relative importance of certain attributes as well as acceptable trade-
offs. Importantly, DCEs can be used to highlight shared but distinct preferences within different groups of Black
adolescent males, which may justify the development of multiple, tailored STI testing models. The Early-
Investigator-led team, with extensive expertise in recruiting Black youth, will accomplish this objective through
two aims: Aim 1 will build the DCE collaboratively with a community-based Youth Advisory Board comprised of
15 Black male adolescents from Atlanta, GA. Qualitative methods such as interviews, focus groups, and pile-
sort exercises will be used to define the testing attributes (e.g., test location, time till results) which are most
important to youth; these attributes will be integrated into the experimental design of the DCE. Aim 2 will leverage
multi-platform community-based and online strategies to recruit a heterogenous sample of 500 Black male
adolescents to participate in a 15-minute online DCE. A latent class analysis will be used to elucidate preference
heterogeneity for STI testing, explore groups or classes with distinct attribute preferences, and assess
associated behaviors/characteristics. The research approach will be anchored in DCE best practices and in the
Phenomenological Variant of Ecological Systems Theory, a framework that recognizes the unique contexts in
which Black youth develop. This R21 innovatively explores a growing health disparity in a population often
neglected in research. Aligning with the NICHD Strategic Plan, this study will engage Black adolescent males in
STI services critical to support their own sexual health and their partners’. Future research will create and test
the acceptability and cost-effectiveness of diverse STI testing models in increasing testing rates among youth.

Public health relevance
PROJECT NARRATIVE With less than 3% of sexually active male adolescents having had an STI test in the past 12 months, these often- asymptomatic infections can be unknowingly transmitted to other sexual partners, they can lead to male and female infertility, and they can increase one’s susceptibility to contracting HIV. Using an innovative, user- centered approach, a discrete choice experiment, the proposed research will determine the distinct preferences for STI testing among groups of Black adolescent males, which will inform the creation of tailored STI testing models. The development and, ultimately, the delivery of such testing models could increase testing and treatment among adolescents, empowering young men in their own sexual wellbeing.